Mechanisms underlying glutamate dyshomeostasis in Alzheimer's disease

The critical neuropathology underlying the cognitive decline in Alzheimer's disease is the loss of
synapses. A leading view of the pathogenesis of Alzheimer's disease is that synaptic abnormalities are
produced that lead to enhanced synapse elimination. The synaptopathy in AD is thought to be due largely to
the production of toxic soluble oligomers of the Aβ1-42 peptide (oAβ). Soluble Aβ oligomers, but not monomers,
have been shown to cause synaptic dysfunction, manifest by inhibition of LTP, enhancement of LTD, loss of
dendritic spines, biochemical abnormalities, and hyperactivity. The enhanced LTD and hyperactivity appear to
be due to elevation of extracellular glutamate as a consequence of impaired glutamate reuptake. Although
substantial evidence has accumulated to support this hypothesis, there are significant gaps in our
understanding of how oAβ perturbs glutamate homeostasis. Specifically, the identity of the glutamate
transporter or transporters targeted by oAβ to produce the defect in glutamate homeostasis is unknown, as are
the molecular mechanisms by which glutamate transport function is compromised by oAβ. These gaps loom
greater in light of recent evidence that monoclonal antibodies (aducanumab; BAN2401) targeting soluble Aβ
oligomers in AD patients may slow cognitive decline. The major glutamate transporter in the forebrain is GLT-
1 (human homolog EAAT2), which represents 1% of brain protein. GLT-1 is expressed in both astrocytes and
glutamatergic axon terminals. Recent work by the applicant using a conditional GLT-1 knockout (KO) has
shown that GLT-1 expressed in axon terminals is the dominant transporter mediating glutamate uptake
into crude synaptosome preparations, also known as plasma membrane vesicles (PMVs). GLT-1
expressed in presynaptic terminals has also been shown to play an important role in synaptic mitochondrial
metabolism. Several studies suggest that in the human and in mouse models deficits in glutamate transporter
expression and/or function occur in AD. In critical experiments, glutamate uptake into PMVs derived from
brain slices was decreased when the slices were treated with oAβ, implicating neuronal GLT-1. The central
hypothesis motivating this project is that GLT-1 is the primary mechanistic target of oAβ causing glutamate
dyshomeostasis. Given these findings it is important to ascertain whether GLT-1 is the specific glutamate
transporter targeted by oAβ, whether oAβ affects GLT-1 function in astrocytes or neurons, or both, and the
molecular basis for the interaction of oAβ with GLT-1. The specific goals of this project are to:
Aim 1: Identify the glutamate transporter whose function is impaired by oAβ.
Aim 2: Determine the cellular localization of effects of oAβ on GLT-1 using a conditional GLT-1 KO.
The pursuit of these goals will lead to a molecular understanding of how oAβ, the salient AD cytotoxins,
perturb glutamate homeostasis in AD and ultimately lead to novel approaches to prevent and treat AD.

Public health relevance
Evidence has accumulated that Aβ oligomers are the salient cytotoxins in Alzheimer's disease, that the cognitive decline associated with the disease is caused by synaptic loss, and that perturbed glutamate homeostasis may be largely responsible for the synaptotoxicity of Aβ oligomers. Glutamate homeostasis in the forebrain is regulated by three distinct glutamate transporters, and, remarkably, a major gap in our knowledge of AD is which glutamate transporters are affected by Aβ oligomers, in which cell types they are affected, and the mechanisms by which glutamate transporter activity is compromised by Aβ oligomers. Addressing these questions is the goal of this project, and it is hoped that by doing so, we will provide a foundation for achieving molecular insight into how Aβ oligomers perturb glutamate homeostasis and a rational basis for novel approaches to prevent and treat AD.